Programmable Microvesicles for Intracellular Macromolecule Delivery

Project Summary
Our project aims to develop a novel technology platform for delivering macromolecules intracellularly
overcoming the challenge of endosomal barriers. Justification for the AKTA Pure 25 M chromatography
system stems from the growing demand for isolating and purifying biological nanoparticles, like
gectosomes, crucial for therapeutic development. Existing methods lack scalability and reproducibility.
The AKTA Pure 25 M's automation, scalability, and compatibility with high-resolution SEC columns are
essential for our research. It will enhance purification efficiency, improving gectosome quality and
scalability, accelerating our research timeline. In summary, the acquisition of the AKTA Pure 25 M will
provide a significant boost to our experimental studies, enhance research efficiency, and foster
collaboration within our research community. This investment will catalyze advancements in
intracellular biologic delivery, benefiting both basic research and therapeutic development endeavors.

Public health relevance
Project Narrative This supplement application requests support to purchase an ÄKTA Pure chromatography system for the efficient and reliable purification of vesicles intended for gene therapy applications. This state-of- the-art instrument supports a wide range of chromatography techniques critical for the isolation and characterization of engineered extracellular vesicles, offering flexibility and scalability. The proposed purchase will enable us to develop a reliable chromatography-based separation method for gectosomes, facilitating its translation into a therapeutic modality.